2025 Germinal Stem Cell Biology Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
Germline stem cells (GSC) are the precursor cells that give rise to gametes (sperm and eggs) for sexual
reproduction. While GSCs are technically unipotent (giving rise exclusively to gametes), they maintain latent
totipotency, ultimately producing the zygote from which all somatic cells of the body will develop. Thus, further
understanding of GSC biology will shed light on important aspects of cell biology, cell fate specification,
genetics, and epigenetics, whilst also underpinning our ability to prevent or cure a wealth of human and animal
diseases. Furthermore, our rapidly improving ability to manipulate these cells in vitro holds promise for major
advancements in reproductive technologies, regenerative medicine, and treatments for infertility and genetic
disorders. The biannual Gordon Research Conference (GRC) on Germinal Stem Cells aims to bring the
world’s leading scientists, engineers, entrepreneurs, and clinicians together to focus exclusively on GSCs, their
origins, their sex-specific maintenance and function, the generation of their progeny via gametogenesis and,
finally, the scientific advances in GSC biology that will lead us towards innovations in the culture, propagation
and manipulation of GSCs for clinical applications. This proposal seeks partial funding for this critical meeting,
along with its accompanying trainee-led Gordon Research Seminar (GRS). The GRC/GRS Germinal Stem Cell
Meetings will take place at the Rey Don Jaime Hotel, Barcelona, Spain on April 27th to May 2nd April 27/28th,
respectively. The location of this meeting in Europe, close to a major international airport, optimizes travel from
across the globe, as reflected by previous participation (35% USA, 40% Europe, 25% Asia/Australasia). The
specific aims are: (1) To convene an international and diverse group of up to 200 researchers to share the
latest innovations in the field, with equal focus on the most impactful recent fundamental research findings and
on the latest innovations and cutting-edge technologies that can be used to address the questions that remain
in the field; (2) To define the current state of the field with respect to translating our basic research findings,
leveraging the potential of GSCs for improving fertility in aging individuals, and for those not capable of
producing healthy gametes of their own; and (3) To continue to enhance diversity and inclusion in our field by
proactively encouraging participation by junior faculty and trainees from historically excluded BIPOC (Black,
Indigenous, People of Color) communities, as well as those with disabilities. To achieve these aims, a program
of 9 plenary sessions and 4 poster sessions will allow leaders in the field, rising stars, and trainees to interact
in an informal setting that optimizes interactions and encourages younger participants to engage in critical
discussions with leaders in the field. An open forum Power Hour will be convened to address the challenges
faced in our scientific community and to seek new ways to improve diversity and inclusion in our field. The
accompanying GRS) allows 60 trainee participants to discuss their research in an informal setting, network,
and acclimatize to the environment of an international meeting ahead of the full GRC convening.

Public health relevance
PROJECT NARRATIVE Germinal stem cells are the precursors of sperm and eggs, so knowledge gains will be important for progress for enhancing human fertility and fertility preservation in older individuals. The goal of the 2025 Gordon Research Conference (GRC) on Germinal Stem Cell Biology is to gather global leaders and up-and-coming scientists in the field to discuss the most recent findings in a collegial, diverse forum, attracting the top basic researchers and clinicians from across the globe. The GRC meeting is preceded by a two-day trainee-led and trainee-focused event: the Gordon Research Seminar (GRS) in Germinal Stem Cell biology, which provides opportunities for trainees and junior investigators to present their research and enhance their career development through interactions with senior and other junior members of the field.